Single Cell Spatial Transcriptomics Shared Instrument at the BCM Core Facility

Abstract
Single-cell omics is a rapidly growing new field that provides many advantages over traditional ‘bulk’ tissue
profiling methods, such as the ability to resolve intratissue heterogeneity in cell types, profile disease
microenvironments, and study rare subpopulations. However, one of the major drawbacks of current single-cell
transcriptome technologies is that they require the isolation of single cells, resulting in the loss of spatial
information. To address this issue, spatial single-cell transcriptomics technologies have been recently
developed, which will enable many new research opportunities. The requested instrument, the MERSCOPE
from Vizgen, is currently the only commercial platform for the recently developed multiplexed error-robust
fluorescence in situ hybridization (MERFISH) technology that allows in situ transcriptome profiling at single cell
resolution. By utilizing error-robust and error-correcting encoding schemes, MERFISH enables massively
multiplexed single-molecule RNA imaging with high sensitivity and accuracy. The shared MERSCOPE
instrument will be placed at and administrated by the established BCM Single Cell Genomics Core (SCGC) to
ensure smooth operation and easy access. We have identified 16 research groups at BCM as users.
Together, these groups have 41 active research projects funded by the NIH and will use 90% of the capacity of
the instrument. The research focuses of these projects are highly diverse, and they are funded by fifteen
institutes at the NIH, including the NICHD, NIAMS, NIDC, NCATS, NIDDK, NEI, NCI, NIA, NIGMS, NHLBI,
NHGRI, NINDS, NIAID, NIEHS, and NIMDH. As the participating PIs are all engaged in both basic and clinical
research, we believe the introduction of this new instrument will have direct, broad, and immediate impact on
many medically relevant fields.

Public health relevance
Project Narrative Baylor College of Medicine requests a MERSCOPE instrument that will be shared among 16 user groups who are engaged daily in both basic and clinical research to be placed at the Single Cell Genomics Core. Their current research projects are highly diverse and are funded by fifteen institutes at the NIH, including the NICHD, NIAMS, NIDC, NCATS, NIDDK, NEI, NCI, NIA, NIGMS, NHLBI, NHGRI, NINDS, NIAID, NIEHS, and NIMDH. The equipment requested will have a large benefit to our research faculty, and we expect an immediate, broad impact on human health as many of these groups work on translational medicine in many different fields.